Molecular Biology and Genetics of Human Tumor Viruses

OVERALL – PROJECT SUMMARY/ABSTRACT
Viruses cause approximately 15% of human cancers. A viral etiology to a human cancer can have substantive
consequences on its treatment and prevention. For example, many virally-caused human cancers express
virally encoded products, which are potential targets for anti-viral, tumor-specific therapies. In addition, unique
sets of cellular genes and pathways contribute to virally-associated cancers, many of which are currently
being pursued as targets for anti-cancer therapies. This program project grant (PPG), now in its 40h year of
continual funding, has two major objectives: to use molecular biology and genetics to elucidate the life cycles
of and transformation by human tumor viruses and to translate this understanding into the identification of
targets for specific anti-viral, anti-tumor therapies. The PPG has eight investigators who share these research
goals in studying human tumor viruses in three different virus families: papillomaviruses, hepadnaviruses and
herpesviruses. Together, these three families of viruses cause the vast majority of virally-associated human
cancers. The PPG has been highly productive over the current funding period with 86 studies published of
which over 25% involve two or more labs, reflecting on the strong synergies arising from the PPG.
Our PPG has a unique organization in which each of five projects have two or more labs working together on
a common theme in human tumor virology. Cross-fertilization of ideas and expertise between projects is
fostered by having many of the eight investigators participating in multiple projects. This interactive and
collaborative organization has been highly fruitful over the current funding period in several regards. Firstly,
each project has been highly productive. Secondly, innovative new ideas and approaches have arisen many
of which are now being used across multiple projects. Thirdly, the collaborative environment created by this
PPG has spawned new interactions that have brought additional expertise to the PPG. Most important of
these interactions are highly productive interactions with two new members of the PPG, Drs. Johannsen and
Sherer, resulting in 12 joint publications with 6 other PPG members over the current funding period and
resulting in their recruitment into Projects 3 and 5, and Projects 2, respectively. The specific themes of this
PPG are: 1) to identify and characterize cellular genes that drive human papillomavirus-associated cancer
and modulate viral infection; 2) to define the intracellular trafficking of components of human hepadnavirus
during the viral life cycle; 3) to study the replication and inheritance of herpesviral genomes in relevant cell
types using novel approaches for live cell imaging; 4) to characterize cellular and viral factors that regulate
the switch from the latent to lytic viral state of Epstein Barr virus (EBV); and 5) to define drivers of EBV-
associated carcinogenesis and develop novel approaches for treating these cancers and diseases caused by
herpesviruses. Three cores provide expertise in A) administration, statistics and bioinformatics, B)
instrumentation, microscopy and histology, and C) virus engineering and production.

Public health relevance
OVERALL – PROJECT NARRATIVE Viruses contribute to at least 21 different human cancers, representing approximately 15% of all human cancers. Understanding how the biology of these human tumor viruses and how they cause cancer will provide new approaches for preventing and treating the associated cancers.